Risk-stratified care for thyroid cancer survivors

Project Summary
There has been an increase in the number of thyroid cancer survivors due to the rise in thyroid cancer
incidence and young age at diagnosis. Although a substantial proportion of these survivors were likely cured
with initial treatment, due to limited data and subsequent inability of physicians to confidently risk-stratify,
surveillance for recurrence continues for many years, often lifelong. Unnecessary surveillance results in
cancer-related worry, additional testing leading to false positive test results, and in some instances,
complications from additional treatments. Through our collaboration with SEER sites Georgia (includes Atlanta,
Greater Georgia, Rural Georgia) and Los Angeles County, we will have access to diverse, population-based
cohorts of patients, in whom we can determine recurrence risk as well as current and optimal long-term
surveillance. Our multipronged data collection strategy will allow us to obtain recurrence details from pathology
reports, augmented with mortality data, patient report, and physician chart review and reporting. External
validation will occur with use of the comprehensive University of Michigan Precision Health data. We will
determine characteristics of cohorts at lower and higher risk of cancer recurrence, use these data to inform
more tailored surveillance care pathways, and then refine surveillance care pathways after assessing trade-
offs and net benefit. The ability to categorize thyroid cancer survivors into meaningful recurrence risk-stratified
groups, tailor surveillance care pathways to recurrence risk, and then refine surveillance care pathways after
assessing trade-offs will inform appropriate long-term follow-up, reduce patient harm, and improve healthcare
costs. This study will dramatically change the care of thyroid cancer patients and will serve as a model for risk-
stratified surveillance for other cancer types.

Public health relevance
Project Narrative The proposed study is key to reducing burden and to improving the quality of thyroid cancer survivorship. The findings from this study will have implications for patients, physicians, and policy makers with potential for a pivotal change in long-term thyroid cancer surveillance.